Finding Solutions for Disparities Associated with Star Ratings

Established by the Centers for Medicare & Medicaid Services (CMS), Star Ratings system for Medicare Parts
C&D (Star Ratings, hereafter) is a health plan quality reporting system with associated bonus payments and
enrollment incentives for health plans since 2012. Researchers have reported the disparity implications of Star
Ratings: e.g., racial/ethnic minorities are more likely to be excluded from measure calculation for diabetes
adherence than non-Hispanic whites, thus minorities may be more likely to be excluded from quality
improvement initiations for this measure, potentially worsening disparities in health. A critical barrier for
resolving such disparities is that comprehensive policy recommendation related to effects of Star Ratings on
racial/ethnic disparities is not available. The goals of this project are to ensure that Star Ratings include a set
of measures that address disparities in measure calculation, and to evaluate the effects of Star Ratings bonus
payments on reducing racial/ethnic disparities in medication utilization. Our strategies are to (1) add to Star
Ratings medication utilization measures selected from Pharmacy Quality Alliance measure concept inventory
(PMCI), and other commonly used medication utilization (CUMU) measures (Star Plus, hereafter), and (2)
compare racial/ethnic disparities in medication utilization before and after the implementation of bonus
payments, and between counties with “double bonuses” and those with regular bonuses. A project focusing on
only medication utilization measures in Star Ratings is warranted because these measures account for a high
percentage in Star Ratings scores (45% in Part D in 2013) and their correlation with other measures is only
moderate. Bonus payments are associated with improved plan benefit structure, which may reduce
racial/ethnic disparities in medication utilization. In the prior grant period we found that selecting appropriate
medication utilization measures may resolve racial/ethnic disparities associated with a Medicare Part D policy.
Our objective of this continuation project is to conduct an analysis of Medicare Parts A/B/D data (2010-2015),
linked to Area Health Resources Files, Orange Book Data Files, and CMS data on double/regular-bonus
counties. We will also conduct disease-specific analysis. Aim 1: Test the hypothesis that using the medication
utilization measures in current Star Ratings negatively affects the health of racial/ethnic minorities. Aim 2: Test
the hypothesis that using Star Plus can lead to a reduction in racial/ethnic disparities associated with Star
Ratings. Aim 3: Test the hypothesis that the Star Ratings bonus payments are associated with reduction in
racial/ethnic disparities in medication utilization. Our expected outcome is to provide policy recommendations
to resolve important disparity issues in Star Ratings among diverse older adults. Impact: This project will help
to align disparity reduction goals with rapidly-proliferating pay-for-performance and public-reporting initiatives.
This project is responsive to the National Institute on Aging's mission-driven strategic goal to “understand
health disparities and develop strategies to improve the health status of older adults in diverse populations.”

Public health relevance
The goals of this project are to evaluate effects of Medicare Parts C&D Star Ratings (Star Ratings, hereafter) bonus payments on racial and ethnic disparities and ensure that Star Ratings include a set of measures that address the disparities in measure calculation. Our expected outcome is to produce comprehensive policy recommendations to resolve important disparity issues in Star Ratings among older adults in diverse populations. Our project will (1) provide the Centers for Medicare & Medicaid Services with information needed to align disparity reduction goals with rapidly-proliferating pay-for-performance and public-reporting initiatives; and (2) provide the National Institute on Aging with support to achieve its strategic goal of “understanding health disparities and develop strategies to improve the health status of older adults in diverse populations.”